Raman Spectroscopic Studies of Amyloids

We have performed foundational studies by Raman spectral imaging towards the goal of studying amyloid formation in cells. This method couples the chemical specificity of vibrational spectroscopy and the spatial resolution of a microscope, so that polypeptide conformational changes can be evaluated and pinpointed. Because intrinsic molecular vibrations are measured, protein secondary structure and cellular biomolecules (e.g. nucleotides and lipids) can be simultaneously observed, offering information unattainable by standard imaging modalities. By leveraging chemical biological approaches, unique vibrational probes have been installed in alpha-synuclein for in vitro and in cellulo studies. We want to understand under what circumstances the protein transforms from a functional to a pathological state and in which cellular compartment. The discovery of initiating sites for alpha-synuclein accumulation would inform on interventional approaches. These studies will provide insights into the biological function of alpha-synuclein and the mechanisms by which alpha-synuclein and its molecular interactions contribute to neurodegeneration.